The role of VacA in Helicobacter pylori-host cell cholesterol homeostasis

PROJECT SUMMARY (ABSTRACT)
Helicobacter pylori is a Gram-negative bacterium that colonizes the stomachs of about half the world’s human
population. Although most infected individuals remain asymptomatic, H. pylori infection can lead to adverse
health outcomes, including peptic ulcer disease, gastric adenocarcinoma, or gastric lymphoma. H. pylori infection
is the primary risk factor for the development of gastric cancer, a leading cause of cancer-related deaths, and
has been designated a Group I Carcinogen by the World Health Organization. Differences in health outcomes
among H. pylori-infected individuals can be partially attributed to the genetic diversity of H. pylori: certain strains
produce virulence factors that are associated with a higher risk of disease development. One of these virulence
factors is Vacuolating Cytotoxin A (VacA), a secreted pore-forming toxin. The vacA gene contains highly
polymorphic regions that vary among strains. Certain forms of VacA display more activity in cell culture, and H.
pylori strains producing these active forms are associated with a higher risk of gastric cancer than strains
producing less active forms. Active variants of VacA form channels in cell membranes and induce a range of
alterations within cells, including the swelling of late endosomes (vacuolation), mitochondrial dysfunction, and
even cell death in certain cell lines. However, the mechanisms by which VacA promotes H. pylori fitness and
modulates host cell function remain incompletely understood. My preliminary studies indicate that VacA
influences host cell cholesterol metabolism by significantly increasing the transcript abundances of genes
involved in cholesterol biosynthesis and altering cellular cholesterol levels. VacA-induced alterations in cellular
cholesterol biosynthesis are likely to be relevant in multiple contexts: (i) VacA binds to cholesterol-rich regions of
host cell membranes, (ii) H. pylori is a cholesterol auxotroph that can acquire cholesterol from host cells, (iii)
dysregulated cholesterol biosynthesis contributes to malignant transformation and gastric cancer risk, and (iv)
statin therapy for high cholesterol has been associated with a lower incidence of stomach cancer in humans. I
hypothesize that VacA disrupts cholesterol host cell cholesterol homeostasis, and that this process
influences H. pylori cholesterol acquisition. The proposed research will address these hypotheses through
three specific aims. In Specific Aim 1, I will further define the specific alterations in gastric cell sterol biosynthesis
triggered by different forms of VacA using enzymatic assays, liquid-chromatography tandem mass spectrometry
(LC-MS/MS), and RT-qPCR. In Specific Aim 2, I will assess the effects of VacA on cholesterol efflux, uptake,
and trafficking using LC-MS/MS and confocal imaging assays. In Specific Aim 3, I will determine whether VacA
influences H. pylori cholesterol acquisition by comparing the cholesterol uptake of VacA-producing strains and
various VacA mutant strains. Taken together, these aims will lead to a better understanding of cellular responses
to VacA and will define the consequences of VacA-induced cholesterol dysregulation for the host and bacteria.

Public health relevance
PROJECT NARRATIVE Infection with Helicobacter pylori, a bacterium that colonizes the stomachs of half the world’s population, is the primary risk factor for the development of peptic ulcers and gastric cancer. This proposal will examine how H. pylori uses its secreted toxin, VacA, to manipulate host cell cholesterol metabolism in order to acquire an essential nutrient. By uncovering mechanisms of VacA-induced cholesterol dysregulation, this research will provide fundamental insights into the pathogenesis of H. pylori infection and H. pylori-mediated gastric diseases.